Enhanced imaging and treatment of aggressive subtypes of prostate cancer

Targeting the prostate-specific membrane antigen (PSMA) with small molecules for imaging and therapy of
prostate cancer (PC) has revitalized the field of nuclear medicine. Few targets have its combination of salutary
attributes, namely, high concentration in malignant with restricted expression in normal tissues, easy access with
recycling to and from the plasma membrane, an enzymatic active site toward which small molecules of high
affinity and specificity can be designed, and biological relevance – an inverse relationship with androgen
signaling while being directly related to degree of malignancy. The ureas that we initially described for imaging
PSMA in 2002 have inspired a wide variety of cancer targeting species from radiotherapeutics to synthetic
antibody mimics. Our goal is to use what we have learned from PSMA-targeted detection, imaging and treatment
of PC to focus on highly aggressive disease, including that which does not express PSMA. We will deploy this
prolific cancer target here by beginning with a project that leverages the considerable clinical data obtained
during the last funding period to refine and simplify PSMA-targeted imaging with positron emission tomography
(PET) – in a way agnostic to imaging agent employed. Complementing PET we will explore sensitive new PSMA-
targeted agents and methods for photoacoustic (PA) imaging, which can characterize primary disease in new
ways in an effort to uncover signatures that could separate aggressive from indolent cancer to prevent
unnecessary surgery and its attendant morbidity. Because PC is a heterogeneous disease, in the second half of
the project we will move from detection and characterization of PSMA-expressing PC to address highly
aggressive, PSMA-negative adenocarcinoma and especially neuroendocrine PC (NEPC), a lethal and
increasingly prevalent subtype with the proliferation of modern anti-androgen therapies. First, we will use a
PSMA reporter gene strategy to track NEPC-targeted chimeric antigen receptor (CAR) T cells in order to gauge
their spatial relationship to tumor, measure their expansion in vivo, and sense their microenvironment, with a
view to improving this case of solid tumor CAR T cell therapy. Finally, we will use cancer cell specific promoter
(CCSP) technology, which we developed for imaging and treating metastases, to enhance PSMA expression
specifically within NEPC tissue so that it may become susceptible to the detection and treatment of its PSMA-
expressing adenocarcinoma counterpart. In addition to using existing PSMA-targeted radiotherapy we will show
how a new urea-drug conjugate we have developed can kill NEPC once it is re-programmed to express PSMA.
To achieve these goals, we take the approach of beginning with a more sophisticated analysis of our clinical
PSMA PET data then work toward more laboratory-based imaging and therapeutic studies also designed for
translation. The team we have assembled is comprised of clinicians and scientists with a track record of high
productivity and impact working together.

Public health relevance
We present a graded approach – beginning with imaging and ending with therapy – to management of advanced, aggressive prostate cancer (PC) by leveraging what we have learned over the past two decades about the prostate-specific membrane antigen (PSMA). We propose machine learning methodology to enhance clinical interpretation of PSMA PET scans for patient management, and development of sensitive, new detection methods using photoacoustic imaging ultimately to avoid unnecessary surgery. We also propose ways to improve immunotherapy for the lethal neuroendocrine subtype of PC and to re-program it to render it more susceptible to emerging PC therapies.